METABOLIC REPROGRAMMING AND PULMONARY VASCULAR DISEASE ASSOCIATED WITH CONGENITAL HEART DISEASE RESULTING IN INCREASED PULMONARY BLOOD FLOW

PROGRAM SUMMARY
Pulmonary vascular disease (PVD) is one of the most critical complications of children born with congenital heart
disease (CHD) that results in increased pulmonary blood flow (PBF). Metabolic reprogramming is increasingly
recognized as a critical component of early pulmonary vascular injury and disease. Vascular morphology studies
in our model demonstrate a >2-fold increase in pulmonary arterioles in Shunt compared to control lambs. This
is opposed to decreased arterial counts in humans with advanced disease. This early increase in angiogenesis
represents an adaptation to increased PBF. Developing a hyperproliferative, anti-apoptotic endothelial
phenotype is necessary for this angiogenic response and requires a dramatic metabolic reprogramming that
supplies these cells with the requisite biosynthetic precursors. A consequence of these metabolic changes is the
loss of NO signaling, the development of endothelial dysfunction, and increased vascular remodeling. We will
extend our investigations into a new metabolic pathway—proline biosynthesis and collagen deposition—in this
competitive renewal. This will significantly boost the impact on three levels: first, mechanistically, the proline-
collagen axis is receiving renewed interest in the PVD field, but little is known of its role in the endothelium;
second, functionally, collagen is a critical regulator of cell proliferation, survival, and angiogenesis; and third,
pathologically, changes in collagen alter the mechanical properties of the vessel leading to increased stiffness.
Proximal pulmonary artery stiffness is increasingly recognized as an early marker of advancing PVD. Overall,
this PPG will continue to focus on increasing our understanding of i) the transcription factors that drive the
metabolic rewiring of pulmonary endothelium, ii) post-translational modifications (PTMs) that influence metabolic
reprogramming, iii) interactions between mitochondrial network dynamics, metabolism, and cellular survival; iv)
how these pathways interact to disrupt hsp90-mediated NO signaling; and v) novel therapeutic strategies for
treating CHD with increased PBF. These represent the thematic underpinning of this PPG. Project 1 will
investigate the paradigm-shifting hypothesis that the mechanically regulated transcription factor, SOX18,
metabolically rewires the endothelium to stimulate proline biosynthesis, leading to collagen deposition and
increased vascular stiffness. Project #2 will continue to build on ongoing studies investigating the role of
mitochondrially localized pp60Src and PTM-mediated regulation of cellular energetics. Project #3 will continue
investigating the role of disrupted mitochondrial network dynamics in developing PVD, focusing on persistent
MFN2 loss in a metabolic reprogramming favoring glutamine-proline metabolism. Each project, along with the
supporting scientific Cores, will focus on integrated and synergistic investigations to continue to increase our
understanding of how the metabolic rewiring of the pulmonary endothelium leads to the hyperproliferative, anti-
apoptotic angiogenic EC phenotype, the loss of NO signaling, endothelial dysfunction, and vascular remodeling.

Public health relevance
RELEVANCE: This PPG application focuses on the critical role of metabolic remodeling in developing pulmonary vascular disease in children born with complex congenital heart defects that result in increased pulmonary blood flow (PBF). This PPG intensely focuses on understanding: i) the transcription factors that drive the metabolic rewiring of pulmonary endothelium, ii) post-translational modifications (PTMs) that influence metabolic reprogramming, iii) interactions between mitochondrial network dynamics, metabolism, and cellular survival; iv) how these pathways interact to disrupt endothelial function; and v) novel therapeutic strategies for treating CHD with increased PBF. Elucidating the contributions of these important cellular pathways to the development of pulmonary vascular disease could lead to improved survival of children born with congenital heart defects.